Ultrafast membrane trafficking at synapses

Project Summary
Neuronal signaling events at synapses determine circuit responses and result in specific behavioral outputs.
This signaling is dynamic - modulated by the history of synaptic activity and perceived stimuli. Defects in
neurotransmission also play a causative role in neurological disorders. However, our understanding of this
process is limited by two factors: size and speed. Over the years, we have developed several techniques in
electron microscopy to visualize changes in protein localization and synaptic ultrastructure associated with
neuronal activity with millisecond temporal precision. Our experiments have revealed key insights into
mechanisms of the synaptic vesicle cycle as well as new parameters controlling synaptic plasticity. However,
many mysteries remain. How do exocytic and endocytic proteins coordinate to mediate membrane remodeling
at synapses on a millisecond time scale? How do these proteins interact with each other and membrane lipids
to perform their functions? How heterogenous are these processes? To address these questions, we will
develop novel approaches in electron microscopy and leverage these tools to dissect the molecular
mechanisms underlying synaptic vesicle exocytosis and endocytosis.

Public health relevance
Projective Narrative Membrane remodeling governs essentially all neuronal functions including synaptic vesicle exocytosis and endocytosis. Defects in these processes lead to neurological disorders, and thus, mechanistic understanding is necessary. In this proposal, we will develop novel approaches in electron microscopy and leverages these tools to understand the millisecond-by-millisecond progress in membrane remodeling during synaptic vesicle cycle.